BEHAVIOR AND ANTHROPOMETRIC FEATURES OF MACROSOMIC AND NORMAL GROWN NEWBORNS

The purpose of this study is to describe the behavior and anthropometric features of macrosomic and normally grown newborns of healthy mothers. Newborns are tested on days 1 and 2 using the Brazelton Neonatal Behavioral Assessment Scale with body measurements obtained on day 2.